Development of CD46 theranostics for imaging and treatment of multiple myeloma

PROJECT SUMMARY AND ABSTRACT
The primary goal of this proposal is to develop novel theranostic agents targeting CD46 for imaging and treatment
of multiple myeloma (MM). CD46 is a novel therapeutic target, with a cognate antibody-drug conjugate, FOR46,
now in phase 1 clinical trials. Our preliminary data demonstrate high expression of CD46 in MM. In this proposal,
we develop and implement [89Zr]DFO-YS5 and [225Ac]DOTA-YS5 as imaging and therapeutic agents targeting
MM. The central hypothesis of this proposal is that CD46 is an effective target for molecular imaging and therapy
of MM. In this proposal we test this hypothesis in preclinical models, and in a pilot study of patients with MM.
In order to test this hypothesis, we have assembled an experienced team of chemists, biologists, imaging
scientists, physicists, and physicians to evaluate this method in preclinical models and in patients. In specific aim
1, we will develop [89Zr]DFO-YS5 and [225Ac]DOTA-YS5 as PET imaging and therapeutic agents for MM. In
specific aim 2, we will develop new co-treatment approaches to maximize CD46 expression, and use these to
augment [89Zr]DFO-YS5 PET and [225Ac]DOTA-YS5 treatment. In aim 3, we perform a pilot [89Zr]DFO-YS5 PET
imaging study in patients with MM, and analyze the data to determine its sensitivity for detecting sites of disease.
The methods developed in this proposal will ultimately be used to develop novel diagnostic and therapeutic
approaches in MM, to help reduce morbidity and mortality for this disease.

Public health relevance
PROJECT NARRATIVE: This proposal describes the development and implementation of theranostic PET imaging and radionuclide therapy agents targeting CD46, an exciting new therapeutic target which is highly expressed in multiple myeloma. We will optimize this strategy in preclinical models, developing co-treatment methods to maximize sensitivity. A pilot translational study of the PET imaging agent will be used to detect CD46 expression in patients with multiple myeloma, setting the stage for widespread clinical translation of these techniques.